Adaptive evaluation of mHealth and conventional adherence support interventions to optimize outcomes with new treatment regimens for drug-resistant tuberculosis and HIV in South Africa

Project Summary/Abstract
Tuberculosis (TB) is the leading cause of mortality among people living with HIV, causing one in
three deaths world-wide. In southern Africa, interaction between TB and HIV epidemics has led
to increased transmission of drug-resistant TB (DR-TB), critically undermining both TB and HIV-
related treatment targets. Bedaquiline (BDQ) is the first new TB drug in over 40 years, and the
World Health Organization recommends the inclusion of BDQ in DR-TB treatment allowing for
more effective, entirely oral DR-TB treatment. Despite challenges, BDQ rollout in South Africa
has been highly successful in reducing TB associated-mortality and improving cure rates.
Dolutegravir, an integrase strand transfer inhibitor, formulated as part of a once-daily combination
antiretroviral therapy (ART), is newly available in the South African public health system.
Tenofovir/lamivudine/dolutegravir (TLD) is superior to older comparator regimens, protective for
discontinuation due to adverse events, and has minimal interaction with BDQ.
The availability of TLD and BDQ has radically transformed the treatment paradigm for DR-TB
HIV but advances in dual adherence support are needed to realize the benefits of new
therapeutics for patients, and to prevent emergent resistance. Patient-centered adherence
support strategies using psychosocial support and mHealth (health practices supported by mobile
technologies) approaches may improve DR-TB HIV outcomes.
The goal of the proposed study is to evaluate an integrated intervention to enhance adherence
to BDQ and TLD. Using a Bayesian, adaptive randomized trial design, this project will efficiently
evaluate the relative contribution of psychosocial support and cellular-supported mHealth
adherence support, in combination and separately, to improve clinical and biological outcomes
for HIV and TB. BDQ adherence measured using cellular-enabled electronic pill boxes, will allow
us to determine optimal adherence thresholds associated with TB culture conversion. We will
use a model-based approach to characterize socio-behavioral mechanisms of action for the
different intervention arms (including potential non-response), and modifiable factors that present
barriers and facilitators to adherence. We will also evaluate the effect of DR-TB HIV intersectional
stigma on adherence. Qualitative methods will allow for longitudinal description of patient-
centered treatment pathways.
Once completed, this study will meet the expressed need of the South African health system
for evidence-based DR-TB HIV adherence interventions and contribute generalizable knowledge
about the relative contributions of adherence support modalities in medically complex patients.

Public health relevance
Project Narrative Novel antimycobacterial agents, including bedaquiline, and combination antiretroviral therapy containing integrase strand transfer inhibitors, newly available in South Africa, have the potential to revolutionize the treatment of drug-resistant tuberculosis (DR-TB) HIV co-infection, but challenges to medication adherence threaten optimal clinical outcomes and emergent drug resistance. Using a Bayesian, adaptive study design, this project will efficiently evaluate the relative contribution of psychosocial and mHealth adherence interventions, separately and in combination, to improve clinical and biological DR-TB HIV outcomes; understand the mechanism of action of the intervention using a socio-behavioral model and the effect of dual DR-TB and HIV stigma on adherence; and use qualitative methods to delineate patient-centered pathways of care. High-level medication adherence improves mortality, treatment outcomes and reduces transmission for TB and HIV; identifying optimal strategies to enhance adherence may benefit individuals and improve population-level TB and HIV control.